CORE--PROTEOMICS

The purpose of the Institutional Development Award (IdeA) Program is to foster health-related research and increase the competitiveness of investigators through support of faculty development and enhancement of the research infrastructure of institutions located in states with historically low aggregate success rates for grant Excellence (COBRE), with the thematic focus of Functional Genomic/Proteomic Analysis of Bacterial- Host Interactions. The proposed COBRE will be headed by an established NIH-funded investigator and includes three new investigators and an established investigator who do not have a prior history of NIH R01 support. This is a state-wide initiative that includes the three major publicly-supported research institutions in the state of Oklahoma: 1) the University of Oklahoma (OU), 2) the Oklahoma University Health Sciences Center (OUHSC), 3) Oklahoma State University (OSU) and the Oklahoma Medical Research Foundation (OMRF), a private research institute located near the OUHSC campus. The proposed Proteomics Core Facility will provide the participating investigators with a capability to analyze proteins by two-dimensional gel electrophoresis and peptide mass fingerprinting for identification of proteins and their post-translational modifications.